Assessing the impact of the substantial equivalence mechanism on the cigarette and cigar markets

ABSTRACT
Tobacco product brand/line extensions continue to proliferate as manufacturers seek to maintain or grow their
market share. The Tobacco Control Act (TCA) introduced a number of potential pathways for marketing
tobacco products, including a substantial equivalence (SE) process. Typically, SE determinations are made by
comparing the “new” product to a pre-existing product in terms of design and emissions, with an eye toward
whether the new product raises different questions of public health than what was previously on the market.
The SE process raises important questions and concerns as to its impacts on the market and on public health.
This understudied area of regulatory science could be leveraged by the tobacco industry to retain or attract
consumers while avoiding the stricter regulatory standard applied to new products. Under the SE regulatory
model in its present form, cigarettes and cigars can continue to evolve through accumulation of small changes
and proliferation of line extensions that bear functional similarity to existing products. Notably, human studies
are not explicitly required for SE determinations, which raises concerns as to whether a product that receives
an SE Order on technical grounds is experienced in the same way as the predicate by consumers. Our
Specific Aims are to evaluate the state of the market with respect to SE determinations and assess
consumer product differentiation in two combustible tobacco product classes – cigarettes and cigars.
These are the products of focus as they are clearly the most associated with health risks, and both of these
markets were very well established prior to the TCA. In Aim 1 we will characterize the marketplace, leveraging
Nielsen data and laboratory techniques to assess the design, contents, and emissions of 15 leading subbrands
of cigarettes and cigars. In Aim 2 we will assess consumer behaviors with respect to substantial equivalence.
In Study 2.1 we will leverage PATH data, which contains self-reported brands and sub-brands, to examine
trends in the market share of brands. In Study 2.2, we will recruit a panel of adults (21+) who currently use one
of the 15 leading subbrands of cigarettes and cigars as identified in Aim 1. The goal of this study is to examine
whether consumers using these products can identify changes to their brand during the course of multiple year
follow-up. In Aim 3, we assess industry behaviors with respect to substantial equivalence by compiling and
integrating SE determinations and other orders posted on FDA’s website to examine trends in product
characteristics and predicate product usage. A key goal is to determine if there are commonalities to what
aspects of product design or emissions are changing, or if there are common predicate products employed.
This proposal addresses the Product Composition and Design, Behavior, and Impact Analysis priority research
domains.

Public health relevance
PROJECT NARRATIVE Tobacco product brand/line extensions continue to proliferate in part due to the substantial equivalence pathway for product authorization. This raises important questions and concerns as to its impacts on the cigarette and cigar market and on public health. This understudied area requires independent evaluation of market share trends, product features, and industry and consumer behaviors.